Development of Tissue-Specific Properties in Central Nervous System Mural Cells

PROJECT SUMMARY/ABSTRACT
Mural cells, encompassing pericytes and vascular smooth muscle cells, line blood vessels and regulate vessel
development, stability, and tone. In the central nervous system (CNS), mural cells have additional, specialized
functions: they regulate the blood-brain barrier, mediate neurovascular coupling, produce neurotrophic factors,
and contribute to molecular transport and metabolism. CNS mural cells are dysfunctional in neurological
disorders including Alzheimer’s disease, cerebral small vessel diseases, and diabetic retinopathy. Reflective of
their functional specializations, CNS mural cells have gene expression profiles distinct from mural cells of other
organs, a phenomenon termed organotypicity. Despite their importance to CNS homeostasis, we have virtually
no knowledge of how these specialized properties arise during CNS mural cell development. CNS mural cells
have two distinct developmental origins (neural crest in retina and forebrain, mesoderm in other regions), but
converge on a remarkably similar molecular profile. This observation suggests that extrinsic signals from
neural tissue control the development of organotypic properties. Further, a novel analysis of transcriptional and
epigenomic data suggest that Wnt/β-catenin signaling and the transcription factors ZIC1 and ZIC4 are key
regulators of this process. Therefore, the proposed project will test the hypothesis that neural tissue-derived
Wnt/β-catenin signaling drives expression of ZIC transcription factors, which activates a CNS-specific
gene regulatory network in mural cells that mediates their specialization. In Aim 1, genetic mouse models
will be used to test whether Wnt/β-catenin signaling is necessary and sufficient to achieve CNS-specific
molecular and functional properties in mural cells. Similarly, in Aim 2, genetic mouse models will be used to
evaluate whether ZIC1 and ZIC4 are required for development of organotypic properties in CNS mural cells. In
Aim 3, transcription factor CUT&RUN and chromatin accessibility profiling will be used to define the gene
regulatory network and cis-regulatory elements controlling CNS mural organotypicity. Together, the proposed
work will advance our understanding of the molecules and signaling networks that govern CNS mural cell
development, which could ultimately be leveraged to develop therapeutic strategies facilitating CNS mural cell
survival or regeneration in pathological conditions. The proposed research project also serves as the basis for
a postdoctoral fellowship training plan, through which Dr. Benjamin Gastfriend (applicant) will receive mentored
training from Dr. Richard Daneman (sponsor) and Dr. Christopher Glass (co-sponsor) at the University of
California, San Diego. Training in rigorous research using genetic mouse models, epigenomic techniques, and
in skills necessary to lead research in an academic setting will synergize with the applicant’s graduate research
and training, and prepare Dr. Gastfriend to make future contributions to biomedical research.

Public health relevance
PROJECT NARRATIVE The specialized properties of blood vessels in the central nervous system (CNS) facilitate proper neural function by exerting tight control over molecular transport and targeting blood to active regions. Mural cells, which line the outside of blood vessels, contribute to these specialized functions through tissue-specific gene expression, yet we do not know how this genetic program is activated during development. This project will improve fundamental knowledge of these developmental mechanisms, which may illuminate new strategies to prevent CNS mural cell dysfunction in neurological diseases.